An Innovative Home Stroke Rehabilitation and Monitoring System

DESCRIPTION (provided by applicant): This proposal demonstrates a novel healthcare delivery system that has the potential to significantly advance stroke rehabilitation monitoring and therapy. The broad, long-term objective is to provide accessible, affordable stroke care for people in rural and underserved areas. A major public health issue is the variability in the quality and quantity of treatment that stroke survivors receive based on their proximity to major metropolitan medical centers. This proposal evaluates a system of stroke patient monitoring and delivery of state-of-the-art stroke therapy for that is accessible for rural residents. This comprehensive rehabilitation delivery system utilizes Web-based platforms for storage and retrieval of patient information in conjunction with easy-to-use robot therapy devices that can be remotely monitored. Collected data are automatically entered into the system and sent to a data center (transparent to the user), where the information is monitored by a clinician through a secure website. To demonstrate the functionality of the system, an existing user-friendly home-compatible stroke therapy robotic device is utilized. A randomized, controlled, multisite clinical trial is designed to evaluate this combination of controlled rehabilitation therapy for stroke survivors with telehealth components. The model can be generalized in the future with the use of other home-based therapy and monitoring devices as needed for a specific patient. Fostering effective home treatments through the use of these devices will help determine the difference between functional independence and nursing home placement. The clinical trial will enroll 96 stroke patients and treat them at home for three months. These important considerations combine contemporary technology for service delivery and the potential for cost-savings. In a relatively short time, these advances will have a major beneficial impact on the delivery of stroke therapy to millions of rural stroke survivors. Kinetic Muscles, Inc. is an emerging company developing state-of-the-art therapy devices to fundamentally improve rehabilitation for people with neurologic injury such as stroke or traumatic brain injury (TBI). As an early stage medical device company, we regularly seek private funding to support growth objectives. Funding of this proposal would not only allow KMI to retain and add four full-time research and development personnel but would also facilitate additional funding from the private investment community to accelerate market deployment of innovative telerehabilitation therapy. This strategy has the realistic capability to provide a new level of accessible, affordable rehabilitative care for stroke patients. It is estimated that this current proposal will also create or retain four jobs between the Cleveland Clinic and Emory University. PUBLIC HEALTH RELEVANCE: The purpose of this research is to evaluate a therapy delivery system for stroke patients that provide accessible, affordable stroke care. User-friendly home therapy robots and a telerehabilitation system are combined to monitor and provide therapy that is accessible for patients in rural and underserved locations.

Public health relevance
Narrative The purpose of this research is to evaluate a therapy delivery system for stroke patients that provide accessible, affordable stroke care. User-friendly home therapy robots and a telerehabilitation system are combined to monitor and provide therapy that is accessible for patients in rural and underserved locations.